FASEB SRC: The Protein Lipidation Conference: Enzymology, Signaling, and Therapeutics

PROJECT SUMMARY/ABSTRACT
Protein lipidation is a central process in cellular function. Lipidated proteins play critical roles in numerous human
diseases including cancer, infectious disease and age-related disorders. We request funds to partially support
the Federation of American Societies of Experimental Biology (FASEB) conference on “Protein Lipidation:
Enzymology, Signaling and Therapeutics” that will be held from July 31 – August 5, 2022 at Vermont Academy
in Saxtons River, VT. Historically, this meeting has brought together scientists in fields ranging from mechanisms
and consequences of acylation, prenylation, and post-prenylation processing of proteins, the synthesis and
transport of intracellular lipids, and the importance of protein-lipid interactions for cellular signaling in specialized
membrane domains. This meeting is the only international venue where these broad but closely interrelated
topics are discussed at length and is the first choice for many scientists. As the field has grown over the past
sixteen years, it has become highly interdisciplinary and this unique meeting allows scientists from different areas
of specialization, ranging from synthetic chemistry to clinical medicine, to come together and discuss new ideas
and form new collaborations. Our confirmed keynote speaker is Maurine Linder, Cornell University who will
present a lecture entitled “Fatty acyl tales of G proteins and PATs”. The conference is organized around four
interrelated themes. First, it will showcase recent advances in structural biology and enzymology of enzymes
involved in protein lipid modification. Second, new developments concerning the roles of lipid modifications in
various physiological processes and diseases will be reported including cancer, infectious disease and age-
related disorders. Third, new methodologies for studying protein lipidation and lipidated proteins will be presented.
Finally, recent therapeutic efforts targeting protein lipidation will be reported. There will be 9 sessions and 37
speakers, including 14 short talks. Graduate students and postdoctoral fellows will give two-thirds of the short
talks, with the other third given by new investigators. We will also include a “Research Snapshots” session in
which 10-15 students and postdoctoral fellows who brought posters but were not selected for short talks in the
main program will be invited to give a 2 minute elevator pitch. To further increase our impact on students and
postdoctoral fellows, two additional events will be held including a career development session and a meet-the-
expert session where experts in four areas including chemistry, cell biology, structural biology and animal-based
research will answer questions. The funds requested for this meeting will be used primarily to support graduate
student and postdoc travel grants and to support the attendance of young investigators and session chairs,
particularly those from underrepresented groups within our research community.

Public health relevance
PROJECT NARRATIVE “Protein Lipidation: Enzymology, Signaling and Therapeutics”, that will be held from July 31 – August 5, 2022 at Vermont Academy in Saxtons River, VT. Lipidated proteins play critical roles in numerous human diseases including cancer, infectious disease and age-related disorders. It is essential to bring together researchers from these fields to share findings, exchange ideas, initiate collaborations and train the next generation of investigators in order to better understand the biology of these cellular processes and develop effective treatments for these diseases.